Neural mechanisms for stopping ongoing speech production

Project Summary
Speech production is timed precisely during conversations. People demonstrate a remarkable ability to adjust
the start and stop time of their speech depending on what others say. The long-term goal of the proposed work
is to understand the neural mechanism that gives rise to the precise control of speech timing during
conversations. Specifically, this proposal focuses on the control for quickly stopping an ongoing production
before an utterance is finished. Neural circuits involved in speech production are found across many cortical
areas, such as the sensorimotor cortex, the premotor and prefrontal cortices. Existing evidence has shown how
these circuits support the generation of speech sound. For example, the ventral part of the sensorimotor cortex
(vSMC) contains a representation of articulators (e.g., lip, jaw, tongue). Neural activity in vSMC encodes the
articulatory kinematic trajectories during speaking. However, little is known about the neural circuit controlling a
sudden stop of speech. This knowledge gap limits our understanding of the principles underlying normal speech
production, as well as the causes of speech and communication disorders like stuttering and aphasia.
The proposal will test the overarching hypothesis that the premotor areas contain a neural network that
distinguishes sensory inputs indicating a stop and generates signals to modulate vSMC for stopping. The
premotor areas provide input to the vSMC and serve important functions in speech preparation and sensorimotor
transformation. Dr. Zhao will incorporate high-density electrocorticography (ECoG) to record neural activities
directly from the human cortex while participants perform speech production tasks. High-density ECoG is a state-
of-the-art technique with fine spatial and temporal resolutions that are well suited for studying the neural
dynamics of speech. Aim 1 will define the premotor signal for the control of speech stopping. Participants are
instructed to make intermittent stops during speech production following visual cues. Aim 2 will determine the
effect of stop activity on articulatory control during stopping. Dr. Zhao will obtain knowledge of articulatory
phonetics and psycholinguistics, and the experimental techniques to measure articulatory kinematic features
during speech stopping. Aim 3 will determine the role of the premotor network for stopping in conversation
contexts. The outcome of this project is expected to provide basic knowledge for understanding the normal
function of speech production, which is necessary for improving treatments for speech and communication
disorders in the future. Dr. Zhao will be supported by a top-tier academic environment and world-class experts
at University of California, San Francisco, and University of California, Berkeley. This grant will provide training
opportunities of human cortical neurophysiology and skills in linguistics, which will facilitate his smooth transition
to an independent investigator.

Public health relevance
Project Narrative Speech and communication disorders often result in aberrant timing in speech production, such as improper stops at places where they should not be. Our understanding of how the brain controls the timing of speech, including the control for making a stop, is still limited. This work proposes to identify key neural circuits that give rise to the control of speech timing and improves the understanding of healthy and disease states of speech neural control in the brain.